Biostatistics Shared Resource

BIOSTATISTICS SHARED RESOURCE: ABSTRACT
Rigorous study design, appropriate analyses, and reproducible results are essential to advancing cancer
research, and the Biostatistics Shared Resource (BSR) plays a key role in this effort through collaborations with
Mayo Clinic Comprehensive Cancer Center (MCCCC) investigators. The BSR team consists of experts in
methodology covering cancer clinical trials, pragmatic trials, cohort studies, cancer detection and interception
studies, high-dimensional data analysis, quality-of-life and patient-reported outcomes, pooled analyses, and
surrogate endpoints. BSR members implement (or create) advanced statistical techniques for MCCCC projects.
Since the last grant renewal, Karla Ballman (ACTS, MCR) has become BSR Director, with Jennifer Le-
Rademacher (CPCS, MCR) as Co-director. Ballman also directs the Bioinformatics Shared Resource (BISR),
fostering integration between the BSR and BISR teams for more efficient and effective collaborations with
MCCCC members.
BSR experts support MCCCC investigators through three Specific Aims:
Aim 1: Collaborate with MCCCC investigators, contributing expertise in study design, analysis, interpretation of
results, and dissemination of findings.
Aim 2: Actively participate in MCCCC Programs and fulfill institutional and administrative responsibilities,
including contributing to educational activities.
Aim 3: Identify or develop appropriate statistical methods.
Collaborations with BSR offer MCCCC investigators a comprehensive suite of statistical support, including expert
considerations in study design, data collection and quality control, and statistical methodologies. BSR provides
insightful data analysis and interpretation and develops advanced statistical methods, as needed. In addition,
BSR engages in educational initiatives, imparting statistical principles and insights to empower researchers.
Collaboration extends to co-authoring abstracts, posters, presentations, and manuscripts. BSR has contributed
to 915 publications (including 252 in journals with an impact factor >10) authored by MCCCC members who
account for 46% of BSR revenue. A key strength is our ability to reproduce analytical results, ensuring the
reliability and transparency of research outcomes. Furthermore, the BSR team engages initiatives to streamline
research processes and enhance institutional efficiency.
Member Utilization 2019-2023: 316 Total (52 CPCS, 34 REDI, 26 CGSM, 38 CII, 49 NTTM, 117 ACTS)
Publication by Members: 915 total, 252 with Impact Factor >10